Oxytocin Induces Retrograde Metaplasticity to Attenuate CocainePreference Behavior

PROJECT SUMMARY/ABSTRACT
A growing number of studies have demonstrated that oxytocin (OXT) provides an attenuating effect on cocaine
reward behaviors in rodents and therefore may be investigated as a potential modulator of cocaine reward
processes. Despite this, the specific mechanism through which OXT exerts this modulatory effect on cocaine-
related behaviors remains unclear. The present research project proposes that OXT attenuates cocaine-
associated preference via a two-fold mechanism on dopamine (DA) neurons within the ventral tegmental area
(VTA). Recent evidence suggests that OXT receptors (OXTRs) on VTA DA neurons both increase tonic firing of
the DA neuron and decreases excitatory inputs, likely affecting phasic activation of the DA neuron. This decrease
in excitatory inputs has been shown to be mediated by an OXT interaction with presynaptic CB1 receptors
(CB1Rs) on glutamatergic terminals. This project investigates the functional relevance of this effect using a novel
combination of transgenic rat and virally-delivered shRNA to silence VTA DA OXTRs or presynaptic
glutamatergic CB1Rs. First, OXTRs on DA VTA neurons will be silenced in male and female rats using a
transgenic Cre rat and Cre-dependent knockdown of OXTRs to determine the effect of OXT-mediated DA firing
rate. Behaviorally, OXT attenuates cocaine preference behaviors, and it is expected that silencing of OXTRs on
VTA DA neurons will diminish this effect. Second, to further elucidate the specific mechanism through which
OXT attenuates cocaine preference via VTA DA neurons, CB1Rs on VTA glutamatergic inputs will be silenced
using a combination of transgenic Cre rat and shRNA silencing of CB1R in the absence of Cre expression. OXT
is known to reduce neuronal excitation through production of endocannabinioids (eCB) that retrogradely reduce
presynaptic input via CB1 receptors. Through this, the effect of glutamatergic CB1R silencing will be assessed on
OXT-mediated VTA DA phasic neuronal firing. Behaviorally, this demonstrates that OXT-mediated reduction of
VTA DA phasic firing underlies OXT-mediated attenuation of cocaine-associated preference. Overall, this project
will utilize a novel combination of tools to investigate the specific neural mechanism through which OXT
attenuates cocaine reward and offer insight into the use of OXT as a therapeutic target for cocaine-related
disorders in males and females.

Public health relevance
PROJECT NARRATIVE Developing evidence has revealed that cocaine reward behavior is attenuated following oxytocin administration in rodents, though the specific mechanisms underlying this effect remains unclear. This research project focuses on oxytocin’s potential mechanism within the male and female rat ventral tegmental area (VTA), a central region of the mammalian reward circuitry. Using a novel combination of transgenic rat and viral-mediated silencing of oxytocin or cannabinoid 1 receptors, this project highlights oxytocin’s impact on dopamine neuronal firing in the VTA through its interactions with the cannabinoid receptors to identify a neural mechanism underlying oxytocin’s effect on cocaine preference behavior.